Administrative Core

The Administrative Core of the University of New Mexico Interdisciplinary Human Papillomavirus Prevention Center (UNM-IHPC), will provide support activities to the Scientific Projects and the Cores of the IHPC with oversight by the Center Director. The IHPC administration will also provide an infrastructure within the UNM Health Sciences Center (UNMHSC) that enhances the interactions within the program and its collaborators and that supports and optimizes accomplishing the interdisciplinary aims of the Center. The goals and objectives of administrating the UNM-IHPC are to: 1) Coordinate activities related to the development of the Center 2) Manage the fiscal resources of the Center 3) Maintain records, monitor and update compliance data related to Projects and Cores 4) Coordinate meetings among investigators and with external seminar speakers 5) Manage and schedule the travel and external reagent exchange and communications for the Center 6) Provide support for noncompetitive renewal reporting including production of an annual progress report 7) Manage requests for use of shared resources developed by the IHPC 8) Interface with all center activities to update the contents of the IHPC website